Molecular mechanisms of UCP1-independent pathways in metabolic health

PROJECT SUMMARY
For over 30 years, a mitochondrial protein, uncoupling Protein 1 (UCP1), was thought to be the only protein
responsible for non-shivering thermogenesis in mammals and all the metabolic benefits associated with active
brown/beige fat. However, recent studies from our group and others show that UCP1-independent pathways
also play a key role in thermogenesis and energy balance. An emerging question is to address the molecular
mechanisms underlying the UCP1-independent pathways.
A particular focus of this proposal is Ca2+ cycling thermogenesis in adipose tissue. We have recently identified
an ER-anchored peptide that acts as a “molecular resistance” to Ca2+ cycling in the microsome. Our preliminary
data suggest that this peptide is required for Ca2+ cycling thermogenesis and whole-body energy balance,
particularly when UCP1-dependent thermogenesis is inactive. Accordingly, we aim to determine the structural
basis, regulatory pathways, and pathophysiological roles of UCP1-independent Ca2+ cycling thermogenesis in
adipose tissue.
Successful completion of the proposed study will advance our fundamental understanding of how UCP1-
independent thermogenesis functions at the molecular, cellular, and organismal levels. Significantly, this study
will establish the hierarchy of UCP1-dependent and UCP1-independent pathways in physiology and disease.

Public health relevance
PROJECT NARRATIVE For over three decades, the mitochondrial protein uncoupling protein 1 (UCP1) was thought to be the primary driver of non-shivering thermogenesis in mammals and responsible for all the metabolic benefits associated with brown/beige fat. However, emerging evidence suggests that UCP1- independent pathways, such as ATP-dependent Ca2+ cycling, serve as alternative thermogenic mechanisms and control energy balance. This proposal aims to elucidate the molecular mechanisms behind UCP1-independent Ca2+ cycling thermogenesis in adipose tissue, focusing on understanding the structural basis, chronic regulatory pathways, and overall impact on energy balance in pathophysiology. Successful completion of this proposal will significantly advance our understanding of thermogenesis and its role in metabolic health.